UTSW Summer Undergraduate Research Institute for the Study of Kidney Diseases

Project Summary/Abstract
Kidney disease constitutes a significant, increasing burden on the United States healthcare
system. Although kidney disease related research has made significant advances on our
understanding of the various conditions that lead to acute or chronic renal insufficiency, little
progress has been made towards finding cures. Focused, concerted efforts by researchers
need to be implemented to advance current knowledge towards translational goals. Such efforts
will be aided by recruiting the best and brightest minds into this field. The UTSW Summer
Undergraduate Research Institute for the Study of Kidney Diseases (SURISKD) strives to
introduce undergraduate students with an interest in biomedical research to the exciting field of
kidney research. Participants spend 10 weeks learning about the kidney and kidney disease by
taking courses from and performing kidney disease-related research in the labs of some of the
leading kidney disease researchers in the world. This program seeks to expose, educate, train
and recruit the future generation of kidney disease researchers.

Public health relevance
Project Narrative This institute aims to engage and train the next generation of kidney disease researchers. Students attend didactic lectures, lab courses and gain hands on lab experience at the hands of world-class researchers in one of the most exciting research institutions in the country. We will attempt to train 14 students per year for the duration of the grant.